Patient specific computational modeling of fluid-structure interactions of cerebrospinal fluid for biomarkers in Alzheimer's disease

Alzheimer's Disease has become a daunting public health concern with devastating effects on the
individual and societal level. Early detection and diagnosis of the disease would be incredibly beneficial in the
effort to reduce morbidity and mortality of the disease, yet reliable methods of early detection remain
frustratingly elusive. Recent work has shown impairment of cerebrospinal fluid (CSF) flow in and around the
brain, and how that impairment is linked to brain tissue stiffness, play a vital role in the early development of
Alzheimer's Disease pathology. Unfortunately, existing candidates for measuring CSF flow and brain tissue
stiffness are either highly invasive or semiquantitative analyses that cannot quantify key mechanical properties
of brain tissue deformation and how it relates to the convective transport of AD-related proteins (such as
amyloid -peptide and phosphorylated tau) via CSF flow. To overcome these obstacles, we will develop a
computational model capable of accurately calculating CSF velocities and the stress-strain status of the
brain cortex. Our approach will use state of the art, non-invasive MRI scans in concert with patient-specific
computational fluid dynamic (CFD) modeling of CSF and blood flow to determine the physiological conditions
of flow in the skull and their interactions with brain tissue. To account for the deformation of brain tissue and
the resulting effects on fluid transport, the fluid simulations will be coupled with a structural model of the brain
tissue via fluid-structure interaction (FSI) modeling. The results from this technique will allow for the
development of novel, noninvasive and quantitative biomarkers such as brain "stiffness" (a surrogate for the
hallmark histopathological plaques and tangles), CSF residence time in the subarachnoid space (related to
protein-removal rates), and other hydrodynamic factors such as intracranial pressure pulsatility.

Public health relevance
Alzheimer's Disease has become a daunting public health concern, yet reliable methods of early diagnosis remain frustratingly elusive. Recent research has shown a link between restricted cerebrospinal fluid flow, brain tissue stiffness, and Alzheimer's Disease pathology. In this work we will develop a tool to investigate this link using patient specific computational fluid dynamic simulations of the CSF and blood flow through the brain, enabling the calculation of brain stiffness and CSF residence time as potential biomarkers for Alzheimer's diagnosis.